Adaptation of Mayaro virus to urban mosquitoes

PROJECT ABSTRACT
The alphavirus Mayaro virus (MAYV) is a mosquito-borne human pathogen that causes febrile illness and
arthralgia in Latin America but has not produced widespread outbreaks like related chikungunya virus (CHIKV).
MAYV infections probably occur after exposure to infected forest-dwelling vector mosquito species. Previous
outbreaks of both CHIKV and Venezuelan equine encephalitis virus (VEEV, another alphavirus) were mediated
by viral mutations that confer adaptation to urban-abundant mosquito species, which facilitated forest-to-city
spillover promoting urban epidemics. One reason MAYV has not produced widespread epidemics may be that
anthropophilic urban Aedes (Ae.) aegypti and Ae. albopictus are incompetent MAYV vectors. Multiple
laboratory vector competence studies from different continents show MAYV poorly infects both species where
doses required for infection are at the higher end or above human viremia levels. Epidemics could result if
MAYV adapts to increase infection and transmission at lower ingested doses in either urban Ae. species since
an increase in mosquito susceptibility means that infected people with low viremias are infectious to
mosquitoes, which can potentiate mosquito-human-mosquito cycling. In earlier studies, we used serial
passaging and sequencing to identify an envelope (E) gene CHIKV mutant know to lower the oral infectious
dose and increase transmission by Ae. albopictus. This work demonstrates the power of experimental
evolution to retrospectively identify epidemiologically relevant alphavirus mutations. However, similar studies
have not been performed for MAYV. The goal of this project is to assess the potential for Mayaro virus to
adapt to urban mosquito vectors using an experimental evolution approach. We hypothesize that MAYV
can adapt via serial Ae. mosquito and alternating Ae.-mouse-Ae. passage to 1) increase infection of and
transmission by Ae. aegypti and Ae. albopictus mosquitoes at lower ingested doses; 2) maintain
transmissibility during alternating cycling; and 3) accrue E gene mutations that augment Ae. infection and
transmission. These hypotheses will be tested by assessing the potential for MAYV adaptation to and
sustained cycling via urban Ae. by (Aim 1A): evaluating fitness of MAYV serially passaged in Ae. aegypti and
albopictus mosquitoes, (Aim 1B): evaluating fitness of MAYV alternately passaged between Ae. and mice, and
(Aim 1C): identifying mutations that arise during MAYV passage and evaluating mutant fitness in mosquitoes.
This project represents the first experimental evolution studies for MAYV in Ae.. Understanding the potential for
adaptation is important to define the risk of future MAYV outbreaks mediated by novel vector use. Knowledge
of mutations that confer MAYV adaptation to Ae. can be used to define mechanisms of increased mosquito
infection and transmission, for inclusion in MAYV vaccine development, and as a target for genomic
surveillance. The use of experimental evolution to predict virus adaptation can lead to a paradigm shift to
enable proactive measures to prevent virus epidemics.

Public health relevance
PROJECT NARRATIVE The alphavirus Mayaro is a mosquito borne pathogen that causes febrile illness in Latin America but has not produced widespread outbreaks like related chikungunya virus. Given that chikungunya epidemics are promoted by viral adaptation to increase infection and transmission in urban mosquito species, the goal of this project is to assess the potential for Mayaro virus to adapt to urban mosquito vectors using an experimental evolution approach. Understanding potential for Mayaro virus adaptation is important for defining risk of future outbreaks.